Vaccinating at Mucosal Surfaces with Nanoparticle-conjugated Antigen and Adjuvant

The incidence of tuberculosis (TB) has increased among Veterans in recent years because global TB burden
has escalated with the emergence of multidrug-resistant and extremely drug resistant Mycobacterium
tuberculosis (Mtb) strains. Further, current vaccines do not elicit long-lasting protective immunity against TB,
especially in adults. Hence, this application addresses a critical unmet need for an effective vaccine against TB
and thereby, significantly improve the quality of life of our Veterans. Herein, we propose pre-clinical studies that
will identify protective CD8+ T cell epitopes and develop intranasal vaccine delivery platforms for the design of
next generation TB vaccines. The global burden of TB caused by Mycobacterium tuberculosis (Mtb) infection is
enormous. A third of the world’s population is currently infected with Mtb, an airborne pathogen that causes ~1.5
million deaths annually. The escalating emergence of multidrug-resistant and extremely drug resistant Mtb
strains for which treatment options are costly and limited, further exacerbates global burden. This problem
persists because current vaccines do not elicit long-lasting protective immunity against TB, especially in adults.
The challenge is multifaceted because Mtb enters the host through the respiratory tract and, therefore, optimal
protection will require installation of lung-resident CD4+ and CD8+ memory T cells positioned at the frontline to
respond immediately to an infection. Traditional vaccines and approved adjuvants typically elicit weak, short-
lived T cell responses, and parenteral vaccination is ineffective at installing protective immunity within the
mucosae. Moreover, most virus-vectored and subunit TB vaccines employ a small subset of Mtb antigens,
resulting in insufficient epitope diversity for optimal protection, partly because the epitopes that are presented
during Mtb infection and confer protective immunity are not fully defined. Hence, our overall objective is to
discover immunogenic, protective Mtb epitopes and to incorporate them in an innovative nanoparticle (NP)-
based intranasal vaccine designed to promote a balanced CD4+ and CD8+ T cell responses in the lungs that are
protective against TB. As a means to accomplish this goal, we discovered >10,000 peptides that bind to HLA-
A*02:01, B*07:02, B*35:01, & B*35:03 in a high-throughput binding assay using ultrahigh-density peptide arrays.
Now the challenge is to identify epitopes recognised by Mtb-reactive CD8+ T cells that can protect against
infection in a preclinical, humanised HLA-Itg mouse models. Moreover, using different infection models, we have
developed multiple nanoparticle platforms for simultaneous delivery of antigens and adjuvants that efficiently
generate protective, tissue resident CD8+ T cells (Trm). Guided by these exciting published and preliminary
results, we will test this central hypothesis: Intranasal immunization with subunit vaccines consisting of novel
Mtb antigens and adjuvant will generate CD8+ Trm responses in the lungs. Installation of Mtb-reactive CD8+ Trm
at the port of pathogen entry will protect against a lethal, aerosol challenge of three novel humanised mouse
models with [there] clinical isolate of virulent Mtb, [including] HN878. Our strategy to test this hypothesis is to,
(a) define immunodominant CD8+ T cell epitopes presented by HLA-B*07:02 that protect B7.2tg mice from Mtb
infections; and (b) define common immunodominant CD8+ T cell epitopes presented by multiple B*07:02-related
alleles [called B7 supertype] that protect HLA-I transgenic mouse models from Mtb infections. Our
multidisciplinary team —consisting of biochemists, immunologists, microbiologists, and bioengineer, is ideally
situated to pursue the stated Specific Aims. We anticipate that successful completion of the proposed research
will inform next generation vaccine design against Mtb infections and TB disease. Our innovative “discover and
deliver” approach to vaccine design will impact clinical practice paradigms against TB and other pulmonary
infectious diseases such as SARS-COVID19 and Flu. Thereby, vaccine paradigms emerging from our research
bears with it the promise to significantly improve the quality of life of our Veterans.

Public health relevance
Our Veterans are susceptible to infections with Mycobacterium tuberculosis—the causative agent of a chronic infectious disease called tuberculosis (TB), causing high morbidity and mortality. This is because the global burden of TB continues to increase with the emergence of multidrug-resistant and extremely drug resistant M tuberculosis strains, and the lack of an effective vaccine that protects adults from infection and the ensuing TB disease. The current application seeks support to develop an effective and durable vaccine that can protect our Veterans. As M tuberculosis is transmitted through aerosols and infects the lung mucosa, the challenge is to install immune effector cells at the site of infection. Our team of immunologists, biochemists, bio-engineers and M tuberculosis experts have found ways to install bacteria-specific immune effectors at the site of infection. Using this preliminary information, we will develop and test a durable vaccine against TB in a preclinical model. This work will lead to the design of a clinical vaccine against TB, and, hence, better the quality of lives of our Veterans.